Development of Tools for Evaluating the National Toxicology Program's Effectiveness

NIEHS conducts research to evaluate agents of public health concern. NIEHS has need for research and development tools for use in its research evaluations for the Division of the National Toxicology Program (DNTP). These research and development activities focus on tools to advance and adopt the use of Artificial Intelligence (AI) and Machine Learning (ML) techniques in the area of literature extraction. Projects focus on increasing efficiency in extracting and summarizing an increasing volume of digital information that is stored in unstructured text, tables, figures, and images. The Department of Energy’s Oak Ridge National Laboratory (ORNL) has research experience in analysis of textual information and unique publication mining capability to enable automated evaluation of scientific publications. DNTP is working with experts in AL/ML at ORNL to develop accurate natural language processing models and image processing models that can augment or replace human effort.